UPCC 6597: SPI 77 IN COMBINATION W/ RADIOTHERAPY ADVANCED LUNG CANCER

The objectives of this trial is to determine: the toxicities of SPI-77 when given concurrent with radiotherapy in patients with advanced lung cancer; to determine the maximum tolerated does (MTD) of SPI-77 when given once every 2 weeks for 2 and 3 doses concurrent with radiotherapy; to determine the pharmacokinetics of SPI-77; and to gather preliminary response information that may result from the treatment of SPI-77 when given concurrent with radiotheraphy.